Dissemination and Stakeholder Engagement Core

Millions of individuals and loved ones are impacted by opioid and other substance use disorders (SUD) and tragic overdoses each year. Yet, as researchers and other health professionals’ quest for empirically supported practices surges, the voices of prospective patients and loved ones are unheard, particularly among those with criminal legal system (CLS) engagement. The Dissemination and Stakeholder Engagement Core (DSEC) extends beyond researcher-practitioner partnerships to include the partnership of patients and loved ones in the development, dissemination, and implementation of evidence-based prevention and treatment services for opioid use disorder (OUD), SUD, and overdose risk behaviors. Recognizing that uptake of effective practices requires not only researcher-practitioner buy-in and engagement but also patient receptivity and uptake, DSEC proposes four aims. Aim 1: Stakeholder engagement with network leadership. To achieve this aim, DSEC will enhance the work of JCOIN 1.0 by establishing a Lived Experience Board of individuals in addition to adding membership to the currently established Practitioner and Stakeholder Boards. Aim 2: Outreach and training for stakeholders. Maximizing the findings from JCOIN 1.0, DSEC will deploy six webinars annually to translate findings of JCOIN 1.0; develop two new courses annually on emerging topics and evidence; and present monthly dashboard reports to stakeholders. Aim 3: Rapid translation of research findings for stakeholder audiences. Aim 3 will be achieved by DSEC developing 12 summaries per year of JCOIN 1.0 and JCOIN 2.0 research findings; three video explainers of the evidence per year; one comprehensive toolkit per year; six fact sheets or issue briefs per year; and numerous dissemination products suitable for newsletters and external stakeholder networks. Aim 4: Identifying and engaging potential sites for future JCOIN activities. DSEC serves as a central resource for the growing network of champions by engaging stakeholders to incorporate concerns and values into the JCOIN processes and will identify sites and partnerships for future JCOIN research. DSEC will accomplish this through marketing efforts and JCOIN’s CONNECT discovery tool, which was developed in JCOIN 1.0 to support researcher-practitioner collaborations. Learning from the feedback of JCOIN 1.0, the proposed JCOIN 2.0 extends DSEC approaches to linking the Lived Experience, Stakeholder, and Practitioner Boards with NIDA leadership and HEAL researchers; partnering with the TA Core to extend outreach to marginalized communities so that those communities and individuals can gain access to scientific discoveries and essential resources such as geospatial tools; increasing stakeholder and patient engagement in the co- production of dissemination materials; and working with the Admin and I-Trans Cores to speed and spread adoption of evidenced-informed policies and interventions. DSEC work will be guided by an Integrated Community Engagement Framework (ICEF) and represents a connection to the vast stakeholders which links researchers to constituents to add value to research, analyses, translation, dissemination, and implementation. This project is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to the national opioid public health crisis. The NIH HEAL Initiative bolsters research across NIH to improve treatment for opioid misuse and addiction.